Cognitive Neuroscience Core

PROJECT SUMMARY: COGNITIVE NEUROSCIENCE CORE
The Electroencephalography (EEG) Core from Phase 1 will be transformed into the Cognitive Neuroscience
(CN) Core in Phase 2 by adding a transcranial magnetic stimulation (TMS) and repetitive TMS (rTMS) suite
coupled with EEG. Located at Kansas State University (K-State), the CN Core will provide resources,
equipment, and technical support to enhance the research capabilities of CNAP projects and programs. The
CN Core will purchase TMS/rTMS equipment, enabling research using virtual lesions and neuromodulation,
two important techniques allowing causal tests of cognitive and neural plasticity. The new equipment
developments will occur in consultation with Dr. Jeffrey Johnson, an EEG/TMS expert and former Co-Director
of the High-Density EEG/Neurostimulation Core at North Dakota State University’s COBRE Center for Visual
and Cognitive Neuroscience (CVCN). The CVCN is a CNAP Scientific Exchange Network (SEN) member. Dr.
Johnson will help establish the new TMS/rTMS with integrated EEG suite, and planned collaborations with him
(e.g., with research project leader Wisniewski) will continue to strengthen the SEN. The CN Core will provide
researchers access to structural and functional magnetic resonance imaging (MRI) facilities at the Hoglund
Biomedical Imaging Center (an SEN partner at the University of Kansas Medical Center) and structural MRI at
a local hospital (Ascension Via Christi, Manhattan, KS). Access to MRI is crucial for targeting brain areas of
interest in TMS research and greatly increasing source localization accuracy in EEG research. To further
develop a critical mass of researchers, the CN Core will hire a new tenure-track faculty member in
Psychological Sciences with research expertise in TMS/rTMS. It will also provide collaborative opportunities for
Dr. Wisniewski, several researchers with current and proposed EEG and/or TMS projects (Bailey, Pitts,
Loschky, Young, Zakrzewski), and other CNAP members. The CN Core will provide training to new users,
such as workshops by CN Core experts and equipment manufacturers. Outreach activities such as wireless
mobile EEG demonstrations will increase CN Core visibility both on- and off-campus. These activities will
promote initiatives to develop a critical mass of researchers in cognitive and neural plasticity. The CN Core will
utilize the Neuroinformatics (NI) Core to support EEG, MRI, and TMS/rTMS data analyses and storage. The NI
Core’s powerful computing resources are crucial for the CN Core high-density EEG, MRI and TMS/rTMS
capabilities. CN and NI Core GRAs will expand ongoing independent components analyses (ICA) and neural
decoding analyses to develop novel machine learning/artificial intelligence tools for users to model data. By
providing access to EEG, TMS/rTMS, and MRI equipment, resources, and training opportunities, the CN Core
will promote CNAP researchers’ ability to successfully compete for extramural funding by providing both key
technologies and technical support to answer the most challenging questions in cognitive neuroscience.

Public health relevance
PROJECT NARRATIVE: COGNITIVE NEUROSCIENCE CORE Not applicable. See Overall plan.